Nonnuclear LXR Beta/Estrogen Receptor Alpha Interaction in Vascular Endothelial Cell Function

PROJECT SUMMARY Disruption of the endothelial monolayer plays an integral role in the initiation of vascular inflammation, which leads to many cardiovascular diseases. Circulating monocytes adhere to vascular endothelial cells (EC) at injured area and migrate into subendothelial layer. Liver X Receptor (LXR) plays an important role in maintaining vascular homeostasis including the suppression of vascular inflammatory responses; however, its role in EC was unknown. In our recent study, we found that LXRβ, a dominant isoform of LXR in vasculature, promotes EC migration and reendothelialization after vascular injury through activating the non-transcriptional action of estrogen receptor (ER) α. We also have evidence that in EC a subpopulation of LXRβ localizes in plasma membrane (PM) caveolae/lipid rafts, and that LXRβ directly binds to and induces ERα phosphorylation via Akt signaling, thereby LXRβ activates the non-nuclear signaling by ERα. Our OVERALL OBJECTIVE is to identify the mechanisms of non-nuclear LXRβ function in vascular EC through the interaction with ERα, and also to examine how non-nuclear LXRβ-ERα interaction plays important roles in the prevention of vascular diseases. Aim 1 is to identify the mechanism by which non-nuclear LXRβ activates ERα. Whether the direct binding of LXRβ to ERα in PM is necessary for the non-nuclear LXR activation via ERα will be tested. In addition, the molecular basis that LXR agonists stabilize the LXRβ-ERα interaction will be tested. Aim 2 is to determine the role of non-nuclear LXRβ function in EC function and vascular inflammatory responses. We will segregate non-nuclear from nuclear effects by the LXRβ-ERα interaction in EC using newly generated mutant ERα knock-in mice that lack non-nuclear but retain nuclear function of ERα. We will also examine the effect by LXRβ activation on EC expression of inflammatory cytokines and cell adhesion molecules as a potential non- nuclear LXR function. The effect of endothelial non-nuclear LXR activation on the monocyte adhesion to EC will be also tested in cell culture and in vivo. Aim 3 is to evaluate the utility of rhodium-LXR agonist conjugates to investigate non-nuclear action of LXRβ. Newly synthesized compound that contain four molecules of GW3965 attached to a rhodium metal center will be examined as a novel tool for non-nuclear-specific LXR activation. Upon completion of this project, we hope to show that non-nuclear crosstalk between LXRβ and ERα is important in vascular EC function, and to further our understanding of the mechanisms by which LXRβ utilizes non-nuclear ERα signaling. Furthermore, this proposed research project has a potential to establish a novel therapeutic approach by improving vascular non-nuclear LXRβ function without detrimental effects observed in the systemic LXR activation.

Public health relevance
PROJECT NARRATIVE Liver X Receptor (LXR) plays important roles in the prevention of cardiovascular diseases. We have discovered that a certain isoform of LXR has novel actions as a rapid signaling molecule, which are mediated by the interaction with the receptor for estrogen. The proposed research program will determine how non- transcriptional signaling by LXR contributes to the protection against vascular diseases through the interaction with estrogen receptors, and this proposed program has a potential to establish a novel therapeutic approach toward vascular diseases by improving this newly-discovered mechanism.